Targeting BCAT1 and branched-chain amino acid metabolism for the detection and prevention of SCLC

Summary
The high mortality of small cell lung cancer (SCLC) is largely due to its invariable resistance to current
cytotoxic therapies. Chemoprevention has been considered as an alternative to existing therapeutics on the
basis of long tumor latency and the well-defined high-risk population (e.g. smokers). Identification of tractable
targets for prevention and early detection requires an understanding of molecular changes underlying early-
stage tumor development. We found that enhanced ribosome biogenesis and protein synthesis are critical for
MYC family-driven transformation of precancerous precursors (preSC) into fully tumorigenic cells. Both human
and mouse SCLC cells are extremely sensitive to a specific inhibitor of ribosome biogenesis that has also been
shown to reduce tumor growth in a genetically engineered mouse model. Analysis of the MYC-driven
oncogenic gene signature revealed branched-chain aminotransferase 1 (BCAT1) as a potential modulator of
both metabolic adaptation and related stress response to promote cellular homeostasis. BCAT1 is an enzyme
that catalyzes transfer of the α-amino nitrogen from branched-chain amino acids (BCAAs including leucine) to
α-ketoglutarate to produce branched-chain α-keto acids (BCKAs) and glutamate. This enzyme routes BCAAs
into multiple metabolite pools for biosynthesis and regulates levels of BCAAs, specifically leucine, that
stimulate protein synthesis by acting as indicators of nutrient availability. BCAT1 has recently been implicated
in multiple types of cancers, including glioblastoma and mouse Kras/p53-driven lung adenocarcinoma. In this
application, we will test the hypotheses that enhanced BCAT1 promotes SCLC development by controlling
protein synthesis and stress response, and that altered levels of BCAA metabolites inform early BCAT1-
dependent SCLC development. To test these hypotheses, we propose the following Aims. Aim 1: To determine
the necessity of BCAT1 for SCLC development, we will evaluate the tumor suppressive effects of knocking out
Bcat1 and examine the effects of pharmacological inhibition of BCAT1 on SCLC development and long-term
survival in vivo. Aim 2: To determine the role of BCAT1 in protein synthesis and stress response during SCLC
development, we will manipulate BCAT1 and determine the resulting impact on biochemical interactions
among related proteins and pathways that influence proliferation and survival of L-Myc-induced transforming
cells, a model of early stage SCLC. We will also determine the significance of BCAA metabolism in tumor
development in vivo by setting up variable conditions that mimic different outcomes of the metabolic reaction
using a BCAA-defined diet. Aim 3: To test alterations in BCAA metabolites as biomarkers for BCAT1-
dependent SCLC development, we will monitor changes in plasma BCAA and BCKA levels during SCLC
development in vivo and examine the clinical correlation of plasma levels of these metabolites with a SCLC
diagnosis. The expected outcome of this proposal will provide critical insights into novel strategies for targeted
prevention using minimally invasive detection methods and intervention using low-toxicity drugs or nutrition.

Public health relevance
PUBLIC HEALTH RELEVANCE Small cell lung cancer (SCLC) is the most aggressive form of lung cancers that affects both men and women and cause deaths of approximately 30,000 patients in the United States and 200,000 patients worldwide each year. Late diagnosis of SCLC often limits treatment options to cytotoxic chemotherapies, which have remained largely unchanged for the past 30 years and failed to significantly improve patient outcomes. The decades-long latency of SCLC and well-defined high-risk population (chronic and former heavy smokers) support the potential viability of prevention strategies. Therefore, novel means for early detection and prevention will significantly improve overall clinical outcomes. We propose to characterize specific molecular changes during early stage SCLC development and assess them as potential biomarkers for early detection and prevention of this devastating disease.